Activity-based protein profiling of the vaginal microbiome

PROJECT SUMMARY
Microorganisms present in the vaginal tract have a profound effect on human health. High
abundance of certain bacteria, predominantly Lactobacillus species, is associated with positive
health outcomes. In contrast, high abundance of non-Lactobacillus taxa is often associated with
increased rates of bacterial vaginosis, increased susceptibility to sexually transmitted infections,
and increased rates of preterm birth. Developing probiotic or drug-based therapies that shift the
community composition of the vaginal microbiome could be one way to prevent or treat these
health conditions. Rational development of such therapies requires a mechanistic understanding
of what controls community composition in the vaginal tract. Achieving such an understanding
has faced major barriers related to the lack of suitable experimental systems. As such,
techniques capable of studying molecular function in human samples of cervicovaginal fluid
(CVF) are needed.
Activity-based protein profiling (ABPP) is a chemical proteomics technique is uniquely suited to
such scenarios. By using small molecule probes, it is possible to covalently label any active
enzymes within complex biological matrices. The labeled enzymes can then be fluorescently
tagged for SDS-PAGE or biotinylated to allow enrichment and identification using mass-
spectrometry based proteomics. This proposal seeks to use ABPP to test the hypothesis that
two classes of enzymes, glycogen degrading enzymes (GDEs) and microbial proteases, are
associated with vaginal community composition and BV. We will achieve this goal in two Aims.
The first will test the hypothesis that distinct GDEs are more active under healthy conditions
relative to BV and identify GDEs that are preferentially active during BV. The second will test the
hypothesis that microbial proteases are more prevalent and active in BV relative to healthy
conditions and determine the molecular identity of these proteases. By applying ABPP, we will
be able to identify the specific enzymes responsible for each activity, providing clear resolution
about which enzymes control each process. This understanding will allow the development of
probiotic strains or novel inhibitors to promote vaginal health and provide a much-needed
treatment option for BV.

Public health relevance
PROJECT NARRATIVE The bacteria that live in the human vaginal tract impact health in a variety of ways, and the presence of certain bacteria such as Lactobacillus species is associated with lower rates of bacterial vaginosis and preterm birth. Identifying how the protective bacteria survive and thrive in the vaginal tract would be one way to prevent or treat these diseases.